Orbitrap Eclipse Mass Spectrometer for Northwestern University Neuroproteomic Collaboration Hub

PROJECT SUMMARY / ABSTRACT
The Northwestern University Proteomics Core requests funds to purchase, install, and operate an Orbitrap
(OT) Eclipse Tribrid mass spectrometer (MS) and ultra-high-pressure liquid chromatography system for
bottom-up proteomic studies. The system will be housed in an available dedicated instrument room within the
Department of Neurology and will be made directly accessible to the Northwestern research community
through the Proteomics Core. The new instrument will be reinforced by the Chemistry of Life Processes
Institute business office which will handle the billing, staff payroll, and post award administration. The existing
four OT instruments available for bottom-up proteomics at Northwestern are constantly overbooked, are
becoming outdated, and the current demand for OT based proteomic analysis far exceeds the available
resources. The User Group has a concentrated and dedicated research base for the proposed instrument and
includes 20 NIH funded projects from 21 PIs which bring more than 6.4M total in direct funds per year from the
NIH. In order to ensure that these projects are impactful and reach their goals, access to a robust and flexible
MS, specifically the requested OT Eclipse is critically important. The new instrument will accelerate the User
Group’s research activities and support a cohort of colleagues who have each previously collaborated to obtain
meaningful proteomic data and published numerous papers together. The User Group predominantly focuses
on interdisciplinary neuroscience research, however moving forward we will build bridges to other areas of
biomedical research including virology, reproductive aging, and cancer. The PI and Core director have several
decades of experience with operating and maintaining modern MS instruments. Over this time, they have
established a record of effective collaboration, shown high productivity, and proven they are dedicated to data
sharing. The proposed instrument will be used in a fair and transparent manner with equal access for all the
major and minor users and will be made accessible the entire NU research community. In this way, the
instrument will elevate productivity across the Northwestern research community, Chicagoland, the Midwest,
and beyond. OT instrumentation has reached new heights and proteomic data analysis workflows have
become more robust, which has triggered an increasing demand for OT MSs. The OT Eclipse will provide
highly sensitive analysis of post translational modifications, reveal new protein-protein interactions, facilitate
accurate multiplexed quantitative proteomic analysis, and add value to all the proposed projects. Ultimately,
the combined capabilities of this instrument will provide a flexible platform for a wide range of investigators to
utilize and will bring a new and missing dimension of analysis that will transform their research programs.

Public health relevance
PROJECT NARRATIVE The ability to determine changes in protein abundance, turnover, and modifications represent a critical step towards identifying the molecular mechanisms underlying human diseases and disorders. By obtaining this Orbitrap Eclipse mass spectrometer a core group of investigators will be able to address important biomedical questions at an unprecedented level and transform their research programs. Ultimately, this new instrument will provide the necessary analytical power to detect and quantify these changes, elevate our knowledge of disease mechanisms, and significantly accelerate the discovery of drug targets for improving human health.